EFFECT OF CYTOKINES ON CELLULAR RESPONSES TO FILARIAL ANTIGEN IN RHESUS MONKEYS

We have shown in our laboratory that rhesus monkeys with multiple inoculations of Brugia malayi L3 develop lymphatic pathology and immune responses to B.malayi adult worm antigen (BmA) that resemble, in many respects, those of human lymphatic filariasis patients. One similarity of the immune response between human and rhesus with brugian filariasis is that both exhibit T-cell unresponsiveness to BmA in vitro. In an attempt to overcome the cellular unresponsiveness to BmA, eight multiple-infected rhesus monkeys whose cells exhibited unresponsiveness to BmA and two uninfected controls were studied. PBMC were co-cultured with antigen and one of the following cytokines that have been reported to be effective in reconstituting T-cell proliferation interleukin (IL)-2, IL- 12, anti-IL- 10, anti-IL-4 and anti-IL- 13. We were able to overcome antigen-specific unresponsiveness in only a minority of the rhesus monkeys studied. Co-culture with either IL-2 or IL-12 were the only conditions which resulted in a slightly enhanced proliferation to BmA in these animals. Even high concentration of every cytokine was unable to render a significant antigen-specific proliferation. The results indicate that more than one distinct immunological mechanism may account for the antigen-unresponsiveness in rhesus monkeys infected with brugian filariasis.